DEVELOPMENT OF MULTI SPECTRAL ACOUSTO OPTICAL MICROSCOPE: TUMOR IMAGING

This project will apply the technique of hyperspectral imaging, via the development of an acousto-optic tunable fiber, to enhance endoscopic imaging for the discrimination of tumors, malignant, and normal tissue. With this system, tissue identification will be based not only on a spectral ratio but on the entire spectrum, thus enhancing the system's sensitivity to very small spectral variations. This system will aquire spectral images of drug or laser induced tissue fluorescence, and will perform near real-time mapping for tumor localization.